Ferumoxytol-Enhanced Cardiac MRI for Ischemic Heart Disease

Project Summary
Ischemic heart disease (IHD) and chronic kidney disease (CKD) are frequent bedfellows, but IHD as the
leading cause of death in this population is under-diagnosed. Although patients with CKD and post-renal
transplant have the highest risk for IHD, reliable estimation of ischemic burden remains a challenge. Accurate
quantification of ischemic burden is crucial for clinical management because invasive interventions may
worsen kidney function. In patients with CKD, cardiovascular event rates increase significantly with increasing
stage of CKD. Contrast-enhanced cardiac magnetic resonance imaging (MRI) is attractive due to the absence
of ionizing radiation and its inherent ability to provide high spatial resolution images. But perfusion cardiac MRI
for defining ischemia relies on the first-pass bolus of gadolinium, which has intrinsic technical shortcomings.
Late gadolinium enhancement for viability is also dependent on gadolinium contrast kinetics. Both are less
suitable for patients with CKD. In patients with renal failure, gadolinium-associated nephrogenic systemic
fibrosis may be fatal and more recently, autopsy results in patients with normal kidney function support
gadolinium accumulation in certain organs and tissues. Our goal is to test and validate a non-nephrotoxic,
steady-state cardiac MRI strategy that overcomes many drawbacks of gadolinium-enhanced cardiac MRI to
detect inducible ischemia and viability. We build upon our collective experience with ferumoxytol-enhanced
MRI and ischemic heart disease. Because ferumoxytol is well-tolerated in patients with renal impairment and
has broad clinical approval for intravenous treatment of iron deficiency anemia, if proven successful, our
steady state stress cardiac MRI approach may also be valuable for other applications.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Chronic ischemic heart disease (IHD) continues to be the number one cause of morbidity and mortality in patients with kidney disease. Contrast-enhanced stress perfusion cardiac magnetic resonance imaging (MRI) for detection of IHD provides high quality images and lacks ionizing radiation, but has technical shortcomings. We propose to develop a new framework for steady state cardiac MRI stress testing that can potentially overcome many drawbacks of stress gadolinium perfusion MRI while heightening its impact across a broad spectrum of patients with renal dysfunction.